SUNBEAM Birth Cohort Supplement

PROJECT SUMMARY/ABSTRACT
No change. Not required per NOFO PA-20-272 Part 2 Section IV Paragraph 2.

Public health relevance
PROJECT NARRATIVE No change. Not required per NOFO PA-20-272 Part 2 Section IV Paragraph 2.